The Role of Energy Balance in Gonadotrope and Reproductive Function

PROJECT SUMMARY
Polycystic Ovary Syndrome (PCOS) is the most common fertility disorder in reproductive-aged women. Women
with PCOS have elevated gonadotropin luteinizing hormone (LH), androgens, glucose, and inflammatory
cytokines. Concomitant increases in LH and testosterone in both women with PCOS and mouse models of PCOS
counter the well-established paradigm that testosterone suppresses the neuroendocrine axis. Mechanisms
behind this paradox are largely unexplored. LH translation and secretion are innately energy-dependent
processes. Therefore, gonadotrope cellular metabolism may explain the counterintuitive relationship between
androgens (anabolic steroids) and LH in PCOS. The overall goal of this proposal is to investigate the impact of
gonadotrope glucose metabolism on LH secretion and fertility in both normal and PCOS-like conditions. The
overarching hypothesis of this proposal is that factors associated with PCOS, including glucose, androgens, and
inflammatory cytokines, perturb gonadotrope energy balance through GLUT1 and therefore alter LH synthesis.
We have determined that glycolysis is the metabolic program required for normal gonadotrope function.
Gonadotropes utilize glucose to support LH production and secretion through Glucose transporter 1 (GLUT1) at
the exclusion of other members of the glucose transporter family. In Aim 1, we will determine the effects of
gonadotrope specific glucose transporter 1 (GLUT1) knock out on female fertility in mice. Using this model, we
will decipher how androgens increase gonadotrope glucose metabolism. We hypothesize that androgens
increase gonadotrope utilization of glucose to drive LH secretion by pre- and post- translational regulation of
GLUT1. We will assess the impact of androgen on glucose uptake after silencing GLUT1 in cell lines and use
gonadotrope specific GLUT1 KO mice to determine the role of gonadotrope GLUT1 in PCOS. In Aim 2, we will
elucidate the contribution of PCOS-induced inflammation to gonadotrope metabolism and function. We
hypothesize that chronic inflammation directly modulates gonadotrope LH secretion and contributes to
reproductive dysfunction in PCOS. Using complex bioinformatic approaches, we will identify the
immunophenotype specific to PCOS and assess the contribution of immune cells to PCOS etiology using
immune deficient transgenic mouse models. Together, these Aims will 1) outline a role for gonadotrope energy
balance in reproduction and PCOS, 2) explain how androgens increase LH, and 3) identify specific inflammatory
pathways as potential therapeutic targets in PCOS.

Public health relevance
PROJECT NARRATIVE Women with polycystic ovary syndrome (PCOS) have pathologically elevated luteinizing hormone despite having high levels of testosterone, a known inhibitor of luteinizing hormone secretion. This proposal will address this incongruity by evaluating cellular metabolism and inflammation as potential mechanisms by which elevated androgens and luteinizing hormone coexist. By explaining this long-standing paradox, this work will identify alternative therapeutic targets, such as inflammation, for the improvement of fertility and metabolic comorbidities in PCOS.